Studies on gut microbiome-joint connections in arthritis

ABSTRACT [Parent R01 Grant - Attached for System-to-System (S2S) Requirements]
Although mechanical overloading of joints has been implicated in the comorbid association between obesity
and osteoarthritis (OA) [1, 2], we and others have established a pathogenic role for obesity-associated
inflammation [3-6]. Our work to further study inflammation in this context has led to new data implicating
dysbiosis of the gut microbiome as a root cause of inflammation in the colon, circulation, and synovium that
culminates in accelerated OA degeneration in joints [7]. Changes include colonic, serum, and synovial
upregulation of inflammatory cytokines, which parallel the expansion of Peptococcaceae and
Peptostreptococcaceae family members in the obese gut. Correction of this dysbiosis via dietary
supplementation with the indigestible prebiotic fiber oligofructose ablates these proinflammatory communities
while restoring an Actinobacteria taxa that is lost in obesity, Bifidobacterium pseudolongum (B.
pseudolongum). This correction leads to reduced inflammation in niches spanning from the colon to the joint,
reduced numbers of macrophages and B cells in the synovium, and protection against the development of OA
in the knee [7]. Moreover, we have discovered that oral delivery of a B. pseudolongum probiotic is joint
protective and the B. pseudolongum metabolome itself contains molecules that directly inhibit inflammation.
Based on these findings, we propose that 1) the OA of obesity is caused by a gut microbiome dysbiosis that
triggers an inflammatory cascade starting in the intestine and radiating to the joint, and 2) obesity-related OA
can be mitigated either by correcting the obese gut dysbiosis using methods to expand B. pseudolongum or by
commandeering its metabolites to reduce inflammation in the colonic epithelium where the obesity-related
inflammatory signature initiates. To investigate these concepts, we propose to address the following two
Specific Aims. Aim 1 is to establish that gut microbiome dysbiosis is causal in the OA of obesity, with the
hypothesis that the obese dysbiotic gut microbiome is the initiator of a systemic inflammatory cascade that
initiates in the colon, radiates to joints, and accelerates OA. Aim 2 is to study how B. pseudolongum protects
against joint degeneration in obesity, with experiments designed to test the hypothesis that B. pseudolongum
mitigates inflammation and is joint protective in the context of obesity and its metabolome contains
inflammation-suppressing agents. Completion of these aims will establish that the OA of obesity is an
inflammatory process driven by gut microbiome dysbiosis. Expansion of B. pseudolongum or delivery of its
metabolites could represent novel therapeutic approaches to address a disease of global scope that is
currently only treated palliatively.

Public health relevance
NARRATIVE [Parent R01 Grant - Attached for System-to-System (S2S) Requirements] This project aims to 1) definitively establish that a pro-inflammatory dysbiotic gut microbiome is causal in the OA of obesity, and 2) demonstrate that correction of this dysbiosis using strategies to expand B. pseudolongum will decelerate the progression of OA in the obese context.